DDT-COA-000-163 Accelerating the FDA COA Qualification Package for thePSYCHS as a ClinRO measure

ABSTRACT
The Clinical High-Risk Syndrome for Psychosis (CHR-P) is a DSM-5-recognized condition affecting youth and
young adults who experience attenuated delusions, hallucinations, and thought disturbances that, while
subthreshold for full psychosis, are distressing and impair daily functioning. Attenuated Psychosis Syndrome
(APS), listed under "Conditions for Further Study" in DSM-5, affects approximately 1.7% of the general youth
population and nearly 20% of youth presenting to psychiatric services, yet remains under-recognized and poorly
served by qualified assessment tools.
Current clinical outcome assessments (COAs) for APS include the Structured Interview for Psychosis-Risk
Syndromes (SIPS) and the Comprehensive Assessment of At-Risk Mental States (CAARMS). Differences
between these instruments have historically hindered harmonization across research and clinical trials. In
response, the National Institute of Mental Health led a harmonization effort that resulted in the Positive
SYmptoms and Diagnostic Criteria for the CAARMS Harmonized with the SIPS (PSYCHS), a semi-structured
ClinRO instrument designed to assess 15 distinct attenuated positive symptoms organized into three general
concepts: attenuated delusions, hallucinations, and thought disorder.
There are currently no FDA-qualified COAs for measuring APS severity in CHR-P clinical trials, presenting a
major obstacle to drug development. The PSYCHS is now implemented in the FNIH-funded AMP SCZ
observational study and will be further evaluated in the upcoming ProCAN randomized controlled trial, which
includes PSYCHS assessments, blinded raters, and ecological momentary assessment. These data provide a
unique opportunity to establish the PSYCHS as a reliable and valid ClinRO for use in regulatory trials.
The objective of this project is to develop a comprehensive Full Qualification Package (FQP) for the PSYCHS.
We aim to: (a) engage the FDA to refine our Qualification Plan through ongoing consultation; (b) systematically
evaluate content validity using input from clinicians, researchers, patients, and trainers; and (c) conduct
preliminary qualitative and quantitative studies to assess test–retest reliability, recall periods, clinically
meaningful change, and within-patient thresholds. The FQP will integrate data from previous studies, ongoing
observational research, and a forthcoming clinical trial to support regulatory qualification of the PSYCHS
instrument.

Public health relevance
PROJECT NARRATIVE The clinical high-risk syndrome for psychosis (CHR-P) is a common condition affecting nearly one in five youth and young adults presenting for mental health services and causing multiple symptoms, including attenuated positive symptoms (attenuated delusions and hallucinations) that are generally distressing and impairing of daily activities and can sometimes progress to serious mental illnesses such as schizophrenia. Clinical trials are urgently needed to develop specific and safe treatments for attenuated positive symptoms in CHR-P patients; however, the absence of an FDA-qualified clinical outcome measure is an obstacle to the design and funding of these trials. This project proposes the development of a Full Qualification Package to support the FDA’s review and consideration of the PSYCHS—a clinician-reported outcome instrument designed to assess the severity of attenuated positive symptoms—for qualification as a Drug Development Tool.